Preventing intimate partner violence among refugee populations in the United States by promoting financial equity in couples

PROJECT SUMMARY
Exposure to war, persecution, and forced migration put FDPs at disproportionately high risk for IPV and
mental health problems. Many FD women, including from the Democratic Republic of Congo (DRC), arrive
from countries where IPV is prevalent, and face increased risk before, during, and after displacement. Foreign-
born women who experience IPV are more likely to be severely injured or killed, and report worse mental
health than US-born women. Financial and social stressors, and persistent gender inequities in the US can
exacerbate both IPV and poor mental health outcomes among FDPs. Yet, US-based programs primarily focus
on connecting survivors to services once IPV occurs, overlooking strategic opportunities to prevent IPV and
poor mental health among FDPs.
In contrast to the US context, there is a rapidly evolving evidence-base of interventions developed globally
that show promise in reducing IPV among FDPs. The EA$E (Economic And Social Empowerment)
intervention (developed by IRC and MPI Wachter), has shown promise in reducing IPV in West Africa in
research led by MPI Gupta. The International Rescue Committee (IRC), a global humanitarian organization,
developed EA$E to address two underlying drivers of IPV in crisis settings--household financial strain and
gender inequity in decision-making--innovatively diminishing risk factors associated with IPV. EA$E leads
couples engaged in economic activities through an 8-session discussion series on household financial
wellbeing, budgeting, spousal communication, and alternatives to violence.
US-based programs for FDPs are in need of primary prevention strategies to address IPV in this health
disparity population. Our overall objective is to advance the nascent science of primary IPV prevention among
FDPs in the US. Our interdisciplinary team (public health, social work) is uniquely positioned to conduct the
proposed study based on our combined expertise in IPV and research and practice with FDPs across settings
and longstanding partnership with the IRC. Guided by the ADAPT-ITT framework, and Cascade
Implementation Framework, we will develop EA$E-US, examine preliminary effectiveness on IPV, and
intervention and intermediary outcomes, and asses implementation outcomes. This is aligned with the US
National Plan to End GBV, which identifies refugees as a priority population.

Public health relevance
PROJECT NARRATIVE Forcibly displaced women and their male partners experience compounding social and structural vulnerabilities to IPV, yet rigorous studies or examples of evidence-based interventions that seek to prevent and reduce IPV among FDPs who seek asylum and rebuild their lives in the US are scarce. Guided by the ADAPT-ITT framework and the Cascade Implementation Framework, we propose to address this gap in research and practice by (1) developing and user-testing the EA$E-US intervention for US-based FD Congolese couples, (2) examining preliminary effects of EA$E-US on IPV outcomes, and 3) examining implementation and processes of EA$E-US.